Development and characterization of engineered therapeutic antibodies against SARS-CoV-2

Project Summary/Abstract
This R01 entitled, “Development and characterization of engineered therapeutic antibodies against SARS-CoV-
2”, builds on our project infrastructure, expertise, and experience in characterizing viral-host factor interactions
in negative strand RNA viruses. Since originating in China, SARS-CoV-2 has since rapidly spread and is now a
global pandemic. Significant concerns are that humans are immunologically naïve, and there are no available
therapies. In the US, the disease has already overwhelmed the healthcare system in some states and have a
serious knock-on effect in exacerbating the standard of care for other diseases. At the time of writing, nearly 5
million cases and >160,000 deaths have been attributed to COVID-19. The virus replicates in the lungs and
causes a severe respiratory disease, COVID-19, which is fatal in >2% of cases. Neutralizing antibodies (nAbs)
generated by natural infection or vaccines is known to control many infections and early studies in the current
COVID-19 pandemic, including studies to test convalescent plasma treatments, are promising. These studies
highlight the potential significance of nAb-based therapy. While IgG format of nAbs have long been the most
extensively used format, early studies, including our own suggest that additional multivalent formats of nAbs may
be more effective. This provides an innovative method to develop nAbs while acquiring potential benefits from
effective neutralization at lower doses and lower likelihood of the emergence of resistance mutants. SARS-CoV-
2 is a single stranded, non-segmented, enveloped RNA virus. Viral infection requires interaction of the spike
glycoprotein receptor binding domain (RBD) to the host receptor ACE2. Here, we will build on newly developed
and established approaches that have been optimized through our work other systems to generate antibodies
targeting spike and spike RBD using phage display technology and characterize their physical properties. We
will engineer antibodies with increased valency and test for potency in in vitro neutralization assays and in vivo
efficacy in a mouse model. At the completion, we expect to provide innovative and unique multivalent nAb leads
with unique characteristics that will rival the best in class IgG drugs.

Public health relevance
Project Narrative SARS-CoV-2 originated in China, but has since rapidly spread across the globe. Now COVID-19 is a global pandemic and is currently making a major impact on the United States. To date, we lack a complete understanding of SARS-CoV-2 pathogenesis and therefore require the work proposed will identify and generate engineered antibodies targeting spike protein with potential application as pre-clinical therapeutic candidates.